Mechanisms of immunoproteasome-mediated metabolic disorders

The parent grant is to understand the roles of hepatic immunoproteasome in inflammatory metabolic diseases.
The central hypothesis of the parent grant is that hepatic immunoproteasome induces metabolic
reprogramming by selective digestion of proteins involved in metabolic homeostasis and anti-inflammation.
As consequences, the immunoproteasome plays important roles in the development of metabolic
abnormalities. Successful outcomes of the parent grant are anticipated to define the immunoproteasome as
a promising therapeutic target for inflammatory metabolic diseases, such as non-alcoholic fatty liver (NAFLD),
non-alcoholic steatohepatitis, and obesity. This supplemental grant is to explore a novel direction of research
that links hepatic immunoproteasome as a therapeutic target for Alzheimer’s disease (AD). This direction of
research has been developed based on our preliminary work in characterizing the liver-specific mouse model
for the immunoproteasome. We found that the liver immunoproteasome is a key factor not only for liver
inflammation but also brain inflammation in metabolically stressed mouse. The liver is the organ most
susceptible to infection, toxicity and stress, and an important organ for AD development. NAFLD is prevalent
in AD patients. NAFLD induced advanced pathological signs of AD in wild type and AD mouse model. The
rising epidemic of NAFLD is associated with cognitive decline and is considered as a major risk factor for AD.
Therefore, effective treatments for NAFLD are anticipated to ameliorate AD pathology. There is not yet an
effective treatment for NAFLD. Our preliminary study showed that depletion of the immunoproteasome in the
liver significantly reduces brain inflammation. Furthermore, depletion of hepatic immunoproteasome improved
metabolism protecting the mice from obesity, insulin resistance and steatosis. Based on these results, we
hypothesize that the immunoproteasome in the liver is a key mediator of metabolic stress for systemic
inflammation that contributes to brain inflammation and amyloid pathology. Whether the liver
immunoproteasome is a promising therapeutic target for HFD-induced metabolic diseases and AD has never
been explored. The liver immunoproteasome shifts the liver capacity to digest many key factors involved in
inflammation, transcription, and signal transduction. We hypothesize that the change in the proteolytic
capacity alters the ability of the liver to take up and clear up Aβ. We propose that targeting the liver
immunoproteasome is a promising strategy to ameliorate AD. In the supplemental grant, we will determine
the effects of hepatic immunoproteasome depletion on AD pathology using AD mouse models. Successful
outcomes will establish a new research direction toward peripheral proteolysis regulation of AD pathology.
Establishing the roles of the liver immunoproteasome in amyloid pathology will advance the knowledge on
AD development and provide new insights into therapeutics for AD.

Public health relevance
This supplemental grant will define hepatic immunoproteasome as a key contributing factor for Alzheimer’s disease. Successful completion of the project will establish a new direction of research investigating the hepatic proteolytic machinery as a therapeutic target for Alzheimer’s disease.